Measuring and describing nucleosome remodeler sequence preferences

PROJECT SUMMARY/ABSTRACT
Hughes - “Measuring and describing nucleosome remodeler sequence
preferences”
Determining how cells interpret regulatory sequence is a difficult but important
problem that broadly impacts disciplines including human genetics, development,
and evolution. Computational approaches in this area are usually focused on
transcription factor (TF) binding sites. There is substantial evidence, however,
that nucleosome remodelers, which work together with TFs to generate open
chromatin at regulatory sites, also possess some level of sequence specificity.
This specificity could involve direct sequence recognition, ability to move or evict
nucleosomes over some sequences but not others, and/or longer-range
mechanisms such as sequence dependence of packing nucleosome arrays
against a barrier.
Here, we propose to develop methods to identify and describe the sequence
dependence of each of these mechanisms, which can be applied to any
remodeling enzyme. To avoid the complex and confounding effects of other
factors, the methods will employ biochemical assays with purified components.
The resulting data will then be interrogated to identify sequence features that
correlate with and predict nucleosome occupancy and movement in response to
each type of remodeler, and models constructed that can detect and score these
features within any given sequence. These models can be used analogously to
and in conjunction with widely used transcription factor motif models.
If successful, these methods could be applied to the many variants of remodeling
complexes. The resulting models should be widely applicable in the study of
gene regulation, analogous to transcription factor DNA binding motifs.
Development and validation of this method could therefore have widespread
impact in human genetic analysis and broad applicability in molecular genetic
research.

Public health relevance
PROJECT NARRATIVE Hughes - “Measuring and describing nucleosome remodeler sequence preferences” The human genome was sequenced 20 years ago, but it remains extremely difficult to decode exactly how it works. After additional tremendous effort, we now know that the genome encodes many more regulatory elements than genes. Knowledge of the locations of the elements does not tell us how they function. It is believed that these elements are recognized primarily by proteins called “transcription factors” which bind discrete elements (usually short DNA sequences) as an ensemble. It remains virtually impossible, however, to precisely describe the mechanisms by which these ensembles of transcription factors recognize some sequences and not others, and how they contribute to gene regulation, in the general case. Here I propose to explore an alternative mechanism, which is that a family of enzymes that move and remove “nucleosomes” – the large proteins that coat the majority of DNA in most cells – have some level of sequence specificity. These enzymes are called “remodelers” and they have been heavily studied in their composition, binding locations, and other biochemical and genetic aspects, but they have not been analyzed in terms of their intrinsic sequence specificity. Such specificity would likely not correspond to short DNA sequences that are bound directly, but would more likely reflect structural features of the DNA and its location relative to the nucleosomes. Specifically, I propose to develop and test a purified biochemical system and associated computational analysis approaches that can be used to identify and describe these sequence preferences.